Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology

Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology
Project Summary/Abstract
The goal of the Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology
(DF/HCC K12) is to prepare the next generation of clinical investigators in oncology to work at the interface of
laboratory science, clinical medicine, and population science. The DF/HCC K12 was first funded in 2002 and
has supported 32 Scholars. The funded Scholars have been exceptionally successful, with an output of 215
publications and 46 grants for Scholars graduating in the past 10 years, and all Scholars progressing to
independent research careers in industry or academic positions. We propose the following Specific Aims for
the renewal of this K12 to continue training physician/scientists from diverse disciplines:
Aim 1: We will recruit and select a diverse group of K12 Scholars. We will issue an annual Request for
Applications (RFA) using a variety of mechanisms to reach the widest possible pool of candidates. We will
aggressively promote the participation of women and other groups traditionally under-represented in medicine.
An Internal Advisory Committee (IAC), comprised of 16 DF/HCC faculty members with leadership roles and
established track records in original research and mentoring, will assist Program Leadership with Scholar
selection. We request a continuation of support for five Scholars per year with two-year appointments and the
potential for one additional year contingent on sufficient progress and continued demonstration of a need for
mentored support.
Aim 2: We will provide a program of rigorous didactic training, career development, and mentored
clinical oncology research. Each Scholar will be guided by two Faculty Mentors, one for laboratory (or data
science) training, and one for clinical investigation. A group of 35 highly qualified and motivated Faculty
Mentors have been identified, but Scholars may elect to include additional mentors from the pool of >1,100
investigators within the seven DF/HCC institutions, as well as faculty from the Koch Institute at MIT and the
Broad Institute of Harvard and MIT. An individualized career development plan will be devised that includes
components of required and optional didactic training, hands-on laboratory research, and development of a
clinical trial. Specific required training has been included that focuses on Diversity, Equity, and Inclusion.
Aim 3: We will monitor the performance and refine the K12 Program to optimize recruitment and
training of new investigators in clinical oncology research. The IAC will review annual progress reports
from Scholars and Mentors and make recommendations for changes in mentoring and/or research focus, as
needed. An External Advisory Committee (EAC), comprised of five PDs from other successful K12 Programs,
will evaluate Program performance, participate in an annual retreat, and provide recommendations for Program
enhancements to the K12 Leadership. The Program will track Scholar productivity, including presentations,
publications, promotions, grants, and clinical trial activity on an annual basis.

Public health relevance
Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology Project Narrative New insights from genome sequencing and technical advances in genome editing, chemical biology, and cellular engineering are providing unprecedented opportunities for advances in cancer treatment. The emerging complexity of cancer biology and increasing sophistication of experimental therapeutics demand a level of understanding and training in research methodology beyond the scope of conventional fellowship programs. To address these challenges, the goal of the Dana Farber/Harvard Cancer Consortium Career Development Program in Clinical Oncology (DF/HCC K12) is to recruit and select a highly qualified and diverse group of Scholars to complete a rigorous two-three year program of didactic instruction and mentored research that will prepare them for independent careers in clinical oncology research.